Implementation of machine learning workflows in primary brain tumor diagnostics

N/A – See Research and Career Development Plan for project details.

Public health relevance
N/A – See Research and Career Development Plan for project details.